Targeting LSD1 to prevent therapy-induced transdifferentiation in BRAF mutant colorectal cancer

PROJECT SUMMARY/ABSTRACT
BRAF activating mutations occur in approximately 10% of metastatic colorectal cancers (CRCs) and are
associated with worse prognosis due to an inferior response to standard chemotherapies. Current standard of
care for patients with metastatic BRAFV600E CRC who have received prior therapy is BRAF inhibitor (BRAFi) plus
EGFRi treatment. Unfortunately, responses are not durable and the median overall survival of patients receiving
combination therapy remains dismal at roughly 9 months. Therefore, improving response to BRAFi plus EGFRi
therapy in metastatic BRAF mutant CRC represents a critical unmet clinical need. With the use of more potent
targeted therapies, shifts in cell identity due to epithelial cell transdifferentiation is an emerging cause of therapy
resistance. In a subset of lung and prostate cancers, lineage transition from adenocarcinoma to a
neuroendocrine phenotype is a mechanism of resistance to EGFRi and anti-androgen targeted therapies,
respectively. However, the phenomenon of “therapy-induced transdifferentiation” has not been examined in
CRC. It was recently determined that BRAF mutant CRC uniquely contains enteroendocrine cell (EEC)
progenitors that promote cancer cell survival via secreted factors and that the differentiation state of these tumors
is regulated by the lysine demethylase LSD1. In new preliminary studies, BRAFi alone or in combination with
EGFRi is shown to further increase the number of EEC progenitors in BRAF mutant CRC. BRAFi treatment is
also found to induce signal transducer and activator of transcription 3 (STAT3) to interact with LSD1 resulting in
EEC progenitor enrichment. Consequently, inhibition or knockdown of either STAT3 or LSD1 blocks BRAFi-
induced enrichment of EEC progenitors. EECs are intestinal neuroendocrine cells and the finding that this
population expands after BRAFi provides strong scientific premise for the overall hypothesis that this lineage
promotes therapy resistance in BRAF mutant CRC. It is hypothesized that BRAFi promotes therapy resistance
by transdifferentiation of BRAF mutant CRCs to an EEC progenitor state through STAT3 and LSD1 activation. It
is further hypothesized that inhibiting LSD1 is a promising strategy to block BRAFi-induced transdifferentiation
and to improve the durability of tumor control with BRAFi plus EGFRi treatment. In Aim 1, the mechanism by
which BRAFi promotes transdifferentiation in BRAF mutant CRC will be determined by focusing on how LSD1
and STAT3 interact to regulate downstream gene expression pathways. In Aim 2, a clinically relevant LSD1
inhibitor will be used in a syngeneic mouse model of metastatic BRAF mutant CRC and human PDX models to
determine the effect of LSD1 inhibition on BRAFi plus EGFRi-induced transdifferentiation, the tumor immune
microenvironment, and efficacy of targeted therapy in vivo. Overall, the proposed work has the potential to
develop an epigenetic inhibitor-based approach to block therapy-induced transdifferentiation, prolong therapy
response, and improve clinical outcomes for patients with BRAF mutant CRC.

Public health relevance
NARRATIVE BRAF activating mutations occur in approximately 10% of metastatic colorectal cancer (CRCs) and are associated with worse prognosis due to an inferior response to standard chemotherapy. With the use of more potent targeted therapy, shifts in cell identity due to epithelial cell plasticity is an emerging cause of therapy resistance. The overall goal of this study is to develop an epigenetic inhibitor-based therapeutic strategy to block therapy-induced shifts in cell identity in BRAF mutant CRC and prolong responses to targeted therapy and improve clinical outcomes for patients with this disease.